OH STEM! Co-Creating a One Health STEM Ecosystem for Rural and Indigenous Alaska Students.

OH STEM!: Abstract
Rural and Indigenous Alaskans are under-represented in biomedical and STEM fields due to systemic bias,
resource disparity, and geographic barriers. In addition, there are pressing local, regional and national needs
for biomedical and STEM professionals with their lived experiences and perspectives. OH STEM! builds on
lessons learned in RASOR (SEPA R25GM129838-01A1; Rural Alaska Students in One-health Research) to
co-create, with tribal partners, an ecosystem of One Health learning and research opportunities that are
culturally-centered and community-based. These efforts will create a sustainable network that encourages
integration of personal, cultural, and science identities, and will result in a greater sense of belonging and
persistence in biomedical and STEM careers. THE GOAL of OH STEM! is to increase representation of rural
and Indigenous Alaskans in biomedical and STEM fields and is supported by our 3 specific aims: AIM 1)
Culture - Implement culturally-centered One Health/STEM curricula to promote belonging and STEM
advancement in Indigenous and rural students. AIM 2) Continuity - Establish a frictionless ecosystem of
advancement pathways for Indigenous and rural student scientists. AIM 3) Sustainability - Create an
integrated, mutually supportive, and sustainable One Health/STEM and Culture network including Tribal
governments, cultural institutions, a Tribal research network and university partners supporting local school
districts and teachers.
OH STEM! will bring One Health experiences and experts to middle and high school students in remote
communities to spark awareness and excitement around STEM education and career opportunities in SE
Alaska. Two dual enrollment, variable credit courses: an Indigenized, place-based One Health Research
course and a new Data and Quantitative Thinking course will give students the opportunity to earn their first
college credits, get matched with a research mentor, investigate a One Health research question, and develop
their critical thinking skills, all within their home community and cultural context. These experiences will prepare
them and connect them to opportunities to present their research, attend a conference, take additional
courses, intern, and work in One health research positions in their community. By emphasizing collaboration,
OH STEM! will facilitate the participation of students in multiple opportunities and scaffold along a continuum
from awareness and engagement to preparation, original contribution, and scientific self-efficacy. We will also
support the development of Southeast Alaska regional capacity to inspire and train STEM professionals with
strong science and cultural identities to meet the particular needs of their own communities. OH STEM! will
holistically integrate Indigenous/local knowledge, Western Science, and cultural values producing researchers
who can contribute unique and multiple perspectives to biomedical issues.

Public health relevance
OH STEM!: Narrative OH STEM! works with tribal partners to create educational opportunities centered in the unique culture and environment of Southeast Alaska for underrepresented rural and Indigneous students. We will bring courses, mentored research projects, and scientists to remote Alaska communities to meet students where they are, while supporting SE Alaska partners to grow their own capacity for STEM education. These culturally centered experiences in their hometowns will develop a foundation of student belonging and resilience as they continue on their science career paths.